Statistical approaches for integrating multi-view, multi-section and multi-sample spatial transcriptomics data to decipher disease mechanisms

Project Summary
Recent technological advances in Spatially Transcriptomics (ST) have enabled gene expression profiling with
spatial information in tissues. Data from ST technologies are typically complemented by high-resolution images
of the same tissue section creating invaluable assistance for the cellular morphology examination. Given that
the availability and affordability of ST technologies are increasing, a number of studies have generated large
ST datasets with multiple sections collecting from multiple samples that profile a broad range of disease
conditions and stages. Population-scale ST data has made it possible to examine intra- and inter-patient
heterogeneity in the tissue microenvironment and holds the potential to uncover biological insights that are not
detectable when individual section is analyzed separately. However, analyzing multi-view, multi-section, and
multi-sample (3M) ST data presents significant challenges due to its rich information and complex data
structure. This proposal aims to provide researchers with a set of analytic tools to tackle these challenges
sequentially, beginning with multi-view analysis, progressing to multi-section integration, multi-sample
comparison, and ultimately achieving cohort-scale ST data analysis. Building upon my expertise in statistical
genomics, I propose the following aims: In Aim 1, we plan to develop a pattern-similarity-aware model to jointly
denoise multi-view ST data. We expect our method to selectively utilize the mutual information across gene
expression and morphological features derived from H&E images by considering their spatial coherence. This
approach should provide denoised data of high quality while minimizing false artifacts, ensuring the quality of
downstream analysis. In Aim 2, we will develop a machine learning method to integrate sequential multi-
section ST data. We anticipate that our method will reconstruct the 3D tissue structure and uncover new
findings through 3D volumetric measurements, which cannot be achieved with 2D analysis. In Aim 3, we will
develop a label transfer method to extrapolate pathologists' annotations from a limited number of samples to
encompass all samples. This will facilitate the construction of a comprehensive multi-sample ST data atlas with
annotations. Subsequently, we aim to establish a systematic framework for cohort-scale comparisons of the ST
data atlas. By analyzing the heterogeneities within specific regions across samples at varying disease stages,
we can gain a comprehensive understanding of various disease mechanisms from multiple perspectives. Such
knowledge is essential for the development of precision medicine, therapeutic strategies involving small
molecules, and their targeted delivery to affected regions. Upon completion of the proposed projects, we
will have developed the very first methods for population-level ST analysis. Our proposed computational tools
will help researchers maximumly mine the rich information in 3M ST data and establish a pipeline for
systematic comparisons between the multi-sample ST data collected at different disease progression stages.

Public health relevance
Project Narrative This proposal bridges knowledge gaps for the cohort-scale Spatial Transcriptomics (ST) data analysis. We aim to develop innovative statistical and machine learning methods for multi-view, multi-section, and multi-sample ST data, to identify the robust molecular and morphological hallmarks associated with disease progression in a spatial context. The resultant findings are demanded for precision medicine, therapeutic development of small molecules and their delivery to a specific tissue domain.